Impact of fentanyl consumption on noradrenergic plasticity in the basolateral amygdala

Project Summary
Opioid use disorders have an enormous societal impact in the United States and opioid overdose deaths are
now the leading cause of accidental death in the United States. The impacts of opioid use disorder have
worsened over the past decade due to prevalence of high potency synthetic opioids, like fentanyl, that pose
unique problems for clinical treatment. Opioid withdrawal is a key contributor to opioid use disorder because
withdrawal acts as a negative reinforcer to drive continued opioid consumption. Opioid withdrawal consists of
both somatic and negative affective behaviors, and long-term opioid use is associated with the development of
anxiety and stress. Therefore, it is critical to understand how opioids alter circuits and neurotransmitters that
regulate addiction-like behaviors and negative affect. The basolateral amygdala (BLA) is a key component of
the stress response and encodes aversive memories. The BLA receives noradrenergic innervation from A2-NE
neurons located in the nucleus of the solitary tract, and this cell population is activated by opioid withdrawal.
Notably, chronic stress disrupts noradrenergic plasticity in the BLA, and altered NE signaling in the BLA
contributes to negative affect and disruptions in conditioned fear extinction. Despite these links, this pathway
has been relatively underexplored in the context of opioid use disorder. My preliminary data demonstrate that
A2-NE neurons are hyperactive and hyperexcitable following morphine withdrawal. I developed a mouse model
of chronic oral fentanyl consumption, where mice consume escalating concentrations of fentanyl for 5 weeks in
a drinking in the dark (DiD) model. I observed sex differences in withdrawal behaviors following naloxone-
precipitated withdrawal. Following fentanyl consumption, BLA principal neurons had reduced
excitatory/inhibitory balance, driven primarily by reduced inhibitory inputs, and increased excitability. Finally, I
found that conditioned fear extinction is reduced following fentanyl consumption, while fear learning itself is
intact. These data inform the central hypothesis of my proposal that will be investigated in 3 aims: 1. Patterns
of fentanyl consumption and withdrawal induce changes in brainstem A2-NE neurons to drive increased
excitability and tonic activity (Aim 1). 2. Increased excitability of A2-NE neurons drives increased NE release in
the BLA, which disrupts BLA NE signaling (Aim 2). Finally, we hypothesize that increased NE
neurotransmission and altered BLA NE signaling drives extinction learning deficits following fentanyl
consumption (Aim 3).

Public health relevance
Project Narrative Opioid use disorders (OUDs) are complex psychiatric conditions in which cycles of opioid use and withdrawal/abstinence are thought to engender both tolerance and dependence, leading to continued opioid consumption despite negative consequences. Recently, the prevalence of illicit fentanyl has greatly increased in the global drug supply, which may have unique consequences for those with OUD, and has already led to a greatly increased opioid overdose death rate. The aim of this proposal is to discover how fentanyl consumption alters stress and fear circuitry in the brain and how these circuit changes affect behavior, which may ultimately lead to the discovery of new targets for therapeutics to treat OUD.